INBRE: UOFL KENTUCKY INBRE ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Administrative Core: The administrative core provides a leadership role in the development of the statewide network. The core is located in approximately 600 sq ft of office space on the Health Sciences campus at the University of Louisville. The office provides budget management services for the network and logistical support for KBRIN committees and their activities. The KBRIN administrative office works with the Grants Management Office at the University of Louisville for the development of subcontracts to KBRIN affiliates and the subsequent invoicing. Dr. Nigel Cooper is Director of the Administrative Core. He is aided by Dr. Bruce Mattingly, the Program Coordinator, who is located at Morehead State University. In addition the Administrative Core is managed on a daily basis by 3 staff including: Ms Stephanie Dearing (budget), Ms Michelle Padgett (reconciliation) and Ms Jane Thornton (logistics). A Steering Committee comprising individuals from each affiliated institution, the PD and the PC meets on a regular basis to provide guidance on programmatic activities and budget distributions.